Targeting Intrinsic and Extrinsic Barriers to Treat Metastatic Pancreatic Cancer

Pancreatic ductal adenocarcinoma (PDAC) owns the ominous ranking as the most lethal malignancy of all major
cancers. These dismal survival rates can be largely attributed to specific intrinsic and extrinsic barriers that foster
metastatic dissemination and impart treatment resistance. Our group and others have demonstrated that
epithelial to mesenchymal transition (EMT), a cellular program intrinsic to tumor cells, promotes metastases and
is a major barrier to treatment efficacy. However, an additional extrinsic barrier exists, notably a signature
immunosuppressive tumor microenvironment (TME) that not only inhibits most anticancer therapies, but also
exacerbates the progression of EMT. This proposal will test the overarching hypothesis that both barriers must
be targeted in order to develop an effective therapy against metastatic PDAC. To accomplish this, our
laboratories have investigated an alternative treatment strategy that administers a therapy directly to the TME
consisting of local radiotherapy and intratumoral immunotherapy. This innovative approach would concentrate
the therapeutic payload to the tumor specifically, which we hypothesized could overcome the
immunosuppressive properties of the PDAC TME. To test this, a novel nanotechnology was generated where a
modified monomeric mRNA sequence of the potent immunostimulatory cytokine interleukin-12 (IL12) was
encapsulated in a lipid nanoparticle (LNP) specifically designed to maximize intratumoral uptake and endosomal
release of the ribonucleic acid when administered directly to the TME. This immunotherapeutic was combined
with localized stereotactic body radiotherapy (SBRT); an emerging radiotherapeutic for the treatment of PDAC,
which augments the efficacy of immunotherapy. The treatment schedule of SBRT (6Gy/day over 4 consecutive
days) followed by an intratumoral injection of IL12mRNA resulted in remarkable tumor elimination and long-term
survival in multiple preclinical models of PDAC. The success of this local combinatorial approach was attributed
to a profound repolarization of the PDAC TME that was now capable of supporting potent antitumor T cell
responses. However, we discovered that although SBRT/IL12mRNA was effective in eliminating metastatic
disease in 70% of mice, 30% of the tumors experienced treatment resistance due to tumor cell mesenchymal
transition. These results suggest that reversing tumor cell EMT will maximize SBRT/IL12mRNA efficacy and
overcome both extrinsic and intrinsic barriers to effective systemic therapy. Aim I will investigate CD4 T cells; a
subset of antitumor effector cells generated in response to SBRT/IL12mRNA treatment, which we hypothesize
are essential to “condition” distal metastases, mediating systemic immunity. Aim II will test a novel therapeutic
targeting Netrin-1 (NP137), a potent inducer of EMT in PDAC tumor cells, and determine how inhibiting
mesenchymal transition overcomes treatment resistance to SBRT/IL12mRNA therapy. This proposal will guide
the development of a new generation of therapies that emphasize both the repolarization of arduous TMEs (an
extrinsic factor), but also the reversal of the mesenchymal phenotype intrinsic to the PDAC tumor cell.

Public health relevance
Project Narrative: Metastatic pancreatic cancer has no effective treatments largely due to tumor cell intrinsic and extrinsic mechanisms that result in therapy resistance. This proposal will investigate a preclinical treatment strategy that specifically targets the intrinsic component, namely the ability of pancreas cancer to metastasize, along with the exquisitely immunosuppressive extrinsic tumor microenvironment. This innovative therapeutic strategy has never been tested before in PDAC and could open a new avenue of research for a malignancy in dire need of effective treatments.